The role of mitochondria-lysosome crosstalk in health and aging

PROJECT SUMMARY/ABSTRACT
The decline of health in aging has long been associated with dysfunctional mitochondria and lysosomes, but
whether the failure of these two organelles is linked remains unclear. The overall goal of this application is to
delineate how mitochondria and lysosomes communicate with each other to promote health in aging. The central
hypothesis is that mitochondria and lysosomes normally communicate with each other to promote health, but
this becomes compromised during aging, leading the two organelles to co-devolve into dysfunction. This is
supported by preliminary data showing that defective lysosomes can activate a mitochondrial stress pathway in
young adult C. elegans. The rationale is that in many aging conditions like Parkinson's disease, both
mitochondria and lysosomes are defective or have familial mutations. If communication between mitochondria
and lysosomes is important, the health decline with aging may result from not only loss of function in the individual
organelles but also from the loss of their synergistic communication. Thus, there is a critical need to understand
how mitochondrial-lysosomal communication adapts to stress and organellar dysfunction in aging. The central
hypothesis of this proposal will be tested by the following specific aims: 1) Identify the stress signaling pathway
connecting defective lysosomes and mitochondria, 2) Define the tissue-specific roles in lysosome-to-
mitochondrial signaling in the aging model organism C. elegans, 3) Determine how lysosome-to-mitochondrial
signaling changes during aging and Parkinson's disease and whether boosting this signaling can rescue health.
This proposed application is innovative because 1) it focuses on the inter-organellar response of mitochondria
and lysosomes to aging-related stress and 2) it will delineate mitochondrial-lysosomal communication in the
multi-tissue aging organism C. elegans. Previous work in mitochondrial-lysosomal interactions used single-celled
systems like yeast and cell culture which cannot fully model aging. The research proposed here is significant
because by defining a novel route of communication between mitochondria and lysosomes required for cellular
homeostasis in stress and aging, this proposal will provide strategies for therapeutic development to restore their
communication during aging.
In addition to the experimental research, this application also proposes a career development plan. Dr. Shen's
career goal is to become an independent, academic investigator in aging science. Completing this proposal will
allow her to establish a research niche in mitochondrial-lysosomal stress communication in aging and gain
technical and leadership skills that are essential for her development into an independent investigator. To help
her achieve her goals, Dr. Shen has assembled a Scientific Advisory Committee to deepen her understanding
of lysosomal biology, RNA-seq, and metabolomics. This award will also give her the opportunity to improve her
scientific writing, mentorship, and communication skills to support her transition into an independent investigator.

Public health relevance
PROJECT NARRATIVE Many aging disorders show defects in mitochondria and lysosomes, but whether these defects are linked and how they contribute to the decline of health in aging is unknown. In this proposal, I will define how mitochondria and lysosomes communicate with each other to understand why defects in these two organelles are so intimately tied to stress in aging. This work will extend our knowledge of how mitochondrial and lysosomal stress responses work together to promote to cellular homeostasis and how targeting this partnership can restore health in aging and age-related diseases.